Biofilm Spatial Structure in the Transition from Health to Periodontal Disease

ABSTRACT
Periodontal disease is mediated by the dynamic interplay between host inflammation and changes in
subgingival biofilm community composition. The keystone pathogen, Porphyromonas gingivalis is known to
subvert the immune response to promote inflammation and favorable conditions for pathobiont organisms,
while inhibiting immune system clearance of bacteria. Because of this, P. gingivalis has been proposed to
initiate periodontal disease. Here we propose a new paradigm for the initiation of periodontal disease,
mediated at the gingival margin by long filamentous cells that bring plaque organisms into close or direct
contact with the epithelium to initiate inflammation in the form of gingivitis. This reversible inflammatory state
then induces dysbiosis in the subgingival community. We will test our hypothesis by imaging intact biofilms on
extracted teeth involved in gingivitis and periodontitis, including the biofilm at the gingival margin with FISH
probes for up to 18 different taxa. We will further perform quantitative comparative structural analyses of
periodontitis associated human biofilms and canine models to specifically identify conserved structural features
of pathogenic subgingival biofilms. Lastly, we will map the spatial location of differentially expressed genes
within filamentous cells in plaque biofilms when these cells are in direct or close contact with specific partner
species. This work will comprise a holistic approach to identify structure-function relationships in healthy and
periodontal disease-associated biofilms that underly periodontal disease initiation and progression.

Public health relevance
NARRATIVE Periodontal disease is affects an estimated 40% of US adults and remains a significant challenge to diagnose at early stages. The work proposed here will foster a better understanding of the structural features of plaque biofilms that are involved in the early initiation of periodontal disease and may foster the development of new strategies to monitor and treat and prevent these diseases.